EFFECTS OF AMINO ACIDS ON LIPOLYTIC ACTION OF CATABOLIC HORMONES

The objective of this study is to determine whether changes in plasma amino acid concentration can modulate the effects of the glucose counter-regulating hormones (epinephrine, norepinephrine, cortisol and growth hormone) on lipid, protein and glucose metabolism in humans.